Resilience Endotype-derivation through Parsimonious Analysis and causal Inference of Recovery from Acute Respiratory Distress Syndrome (REPAIR-ARDS)

Project Summary
Acute Respiratory Distress Syndrome (ARDS) is a serious lung injury requiring critical and complex care in the
Intensive Care Unit (ICU). ARDS results in increased capillary permeability and fluid build-up in the lungs
which affects oxygen delivery to red blood cells and leads to non-compliant or "stiff" lungs. Sepsis and trauma
remain the major contributors to ARDS among patients admitted to the ICU. Each year, more than 200,000
Americans are diagnosed with ARDS and receive intensive care treatment, resulting in more than 3.6 million
hospital days. Mortality rates are extremely high, with an average reported figure of 43% overall, representing
a disease deadlier than ischemic heart disease and embolic stroke. There is still no pharmaceutical treatment
available for ARDS; however, a number of interventions have been shown to be highly effective in reducing
mortality. ARDS continues to be underdiagnosed and missed in up to half of the mild cases. This prevents the
judicious and timely applications of effective interventions that have been proven to reduce mortality. Our
project seeks to develop and validate predictive models of ARDS using protein biomarkers and clinical
data for early diagnosis (Aim 1). Early detection of ARDS using parsimonious biomarkers is needed to
improve recognition and timely administration of supporting interventions. We also seek to elucidate
resiliency markers and endotypes associated with ARDS recovery using an integrated multiomics
pipeline (Aim 2). Underlying biological mechanisms that drive severity and recovery are still unknown. There
is now a distinct interest in identifying ‘host-factor resilience’, defined as ability of a host to tolerate the effects
of an infection or other significant perturbation and promote salutogenesis. Our main goal is to characterize
such protective factors among those who recovery to discover possible therapeutic targets of ARDS. This
complex undertaking necessitates a holistic analysis supported by the integration of multiomics sources, such
as transcriptomics, metabolomics, proteomics and lipidomics to gain crucial insights into the host-factors that
drive resilience and recovery among the critically ill patients.

Public health relevance
Project Narrative Acute Respiratory Distress Syndrome (ARDS) is a devastating, highly heterogenous condition that occurs among 10% of critically ill patients, for which there are currently no treatments, and with mortality rates as high as 80% in the elderly and 43% overall. We seek to utilize state-of-the-art machine learning methodologies applied to time-course based analysis of clinical and multi-omics data to elucidate complex immunological processes that may be driving disease severity and/or resilience. Our overarching goals are to (1) develop and validate predictive models of ARDS using protein biomarkers and clinical data for early diagnosis and (2) elucidate resiliency markers and endotypes associated with ARDS recovery using an integrated multiomics pipeline.